Genetics of Alopecia Areata in the C3H/HeJ Mouse

DESCRIPTION (provided by applicant): Alopecia areata (AA) is a disfiguring human autoimmune skin disease with a complex genetic basis that targets hair follicles in the actively growing anagen phase and is often associated with other systemic autoimmune diseases. Psychogenic trauma due to hair loss, particularly for teen-aged girls, can be so serious as to lead to suicide. AA can affect up to 2% of the general population at some time during their lives (6,000,000 US citizens). C3H/HeJ mice spontaneously develop AA and, like in humans, this is a very complex polygenic disease with susceptibility loci in common with both human AA patients and the rat AA model. Our previous hypothesis was that AA was due to the interaction of immune-regulatory genes affecting pathways that can be identified by systematic analysis of gene expression levels within each quantitative trait locus (QTL) interval previously identified. While this idea remains viable, we have now identified genes within these QTLs which go beyond immune regulatory genes towards explaining many of the key issues in the pathogenesis of this extremely complicated disease. Gene array data from a cross sectional AA study (completed, including mice with spontaneous disease), when combined with quantitative real time RT PCR (QPCR) for all genes within each of the 4 AA quantitative trait loci (QTLs) and haplotype mapping data based on total genomic sequencing (Sanger draft sequences), will be used to identify numerous candidate genes involved in the pathogenesis of AA that will allow for prioritization of molecular pathways for future intervention trials. To validate this work we will use a prototype mouse AA-specific QPCR 384 gene array (completed) to provide expression based phenotyping capabilities, adding Expression-based Quantitative Trait Locus (EQTL) analytical methods to analyze new genetic crosses. By evaluating mice that develop AA in the separate aging of Collaborative Cross mice (nearly 200 carefully genotyped novel mouse strains that provide expanded genetic diversity), we will identify new QTLs and refine the known QTLs. In so doing, we will reduce the mouse genetic intervals, find and test candidate genes, identify new loci, and validate our new molecular tools that will eventually add value to drug and diagnostic screening approaches. Discoveries using this mouse model continue to contribute to a better understanding and treatment options for human AA, especially since recent human genetic linkage studies found corresponding genetic intervals to those in our mouse model.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alopecia areata is a relatively common (up to 2% of the population, 6,000,000+ people, during their lifetime) autoimmune disease that causes severe psychological stress. Our mouse model provides a comprehensive understanding of this extremely complex genetic disease. Over 38 genes are dysregulated in the major quantitative trait locus and, with these data, plus that from the 3 minor loci, the major molecular network has been defined that leads to this cell mediated autoimmune skin disease. One of the major structural proteins in the hair was identified that is downregulated resulting in fragility and breakage, the clinical presentation of alopecia areata. Environmental (vitamin A levels in the diet) effects on disease severity were first identified in the mouse and recently confirmed in human patients. Refining and expanding these observations will help us understand the genetic basis of alopecia areata. Changes in gene networks associated with alopecia areata disease progression and success or failure of drug efficacy screening studies will provide new tools to accurately diagnose the human disease and predict optimal treatment regiments. Relevance to Public Health Alopecia areata is a relatively common (up to 2% of the population, 6,000,000+ people, during their lifetime) autoimmune disease that causes severe psychological stress. Our mouse model provides a comprehensive understanding of this extremely complex genetic disease. Over 38 genes are dysregulated in the major quantitative trait locus and, with these data, plus that from the 3 minor loci, the major molecular network has been defined that leads to this cell mediated autoimmune skin disease. One of the major structural proteins in the hair was identified that is downregulated resulting in fragility and breakage, the clinical presentation of alopecia areata. Environmental (vitamin A levels in the diet) effects on disease severity were first identified in the mouse and recently confirmed in human patients. Refining and expanding these observations will help us understand the genetic basis of alopecia areata. Changes in gene networks associated with alopecia areata disease progression and success or failure of drug efficacy screening studies will provide new tools to accurately diagnose the human disease and predict optimal treatment regiments. __SpecificAimsTextDelimiter__ Specific Aims. Alopecia Areata (AA) is a disfiguring human autoimmune skin disease with a complex genetic basis that targets hair follicles in the actively growing anagen phase and is often associated with other systemic autoimmune diseases. Psychogenic trauma due to hair loss, particularly for teen-aged girls, can be so serious as to lead to suicide. AA can affect up to 2% of the general population at some time during their lives (6,000,000 US citizens). We discovered that C3H/HeJ mice spontaneously develop an AA-like disease resembling human adult onset AA. This mouse AA-like disease is a complex polygenic trait with susceptibility loci in common with both human and rat AA. Our previous hypothesis was that AA was due to the interaction of immune-regulatory genes affecting pathways that can be identified by systematic analysis of gene expression levels within each quantitative trait locus (QTL) interval previously identified. While this idea remains viable, we have now identified genes within these QTLs which go beyond immune regulatory genes towards explaining many of the key issues in the pathogenesis of this extremely complicated disease. Combining gene arrays, quantitative real time RT PCR (QPCR) for all genes within each of the 4 AA QTLs, and haplotype mapping (Sanger draft sequences), we will identify numerous candidate genes involved in the pathogenesis of AA. This will allow for prioritization of molecular pathways for future intervention trials. To validate this work we will use a prototype mouse AA-specific QPCR 384 gene array (completed) to provide expression based phenotyping capabilities, adding Expression-based Quantitative Trait Locus (EQTL) analytical methods to analyze new genetic crosses. By including mice that develop AA in the aging Collaborative Cross (nearly 200 carefully genotyped novel mouse strains), we will identify new QTLs and refine the known QTLs. In so doing, we will reduce the mouse genetic intervals, find and test candidate genes, identify new loci, and validate our new molecular tools that will eventually add value to drug and diagnostic screening approaches. Discoveries using this mouse model continue to contribute to a better understanding and treatment options for human AA, especially since recent human genetic linkage studies found corresponding genetic intervals to those in our mouse model. To do this we will: Specific Aim 1. Refine QTL intervals, design QPCR arrays to include all genes within the intervals, and delineate Alopecia Areata (AA) candidate genes. Our hypothesis is that AA in the C3H/HeJ mouse is a complex genetic disease with substantial clinical and genetic similarity to human AA. Breaking up the genetic intervals and identifying mouse AA susceptibility and pathogenesis genes are critical approaches for identifying the genes responsible for human AA. Consequently, disease mechanisms can be elucidated and new drug targets identified. We identified 4 QTLs in our AA mouse model (Alaa1, Chr 17; Alaa2, Chr 9; Alaa3, Chr 8; and Alaa4, Chr 15) with Alaa1 having the highest LOD score (major QTL). We will take the following approaches to break up the genetic intervals (<1 Mb) and find candidate genes in all 4 QTLs: A) Continuation of the (C3HB6)F2 cross to utilize EQTL approaches to provide true quantitative data, B) a new cross between affected A/J and C57BL/6J mice, C) haplotype association gene mapping using data generated by The Jackson Aging Center (expanded to include the Collaborative Cross), D) systematic screening of all genes (within QTL intervals) for expression using QPCR arrays, and E) systematic analyzing haplotype data for each gene within all 4 QTLs using the new Sanger draft genomic sequence data for inbred strains and associated software. These analyses will be linked to significant changes in gene expression. Dysregulated genes (non- synonymous SNPs in coding and regulatory regions) will be sequenced to confirm genomic sequence data. In this manner, we will build on existing resources utilizing the latest technology to break-up the 4 QTLs and systematically test promising genes to identify the key genes involved in all aspects of the pathogenesis of AA. Specific Aim 2. Test candidate genes for alopecia areata (AA) and QTL interactions. Our hypothesis is that the effect of single or multiple mutant genes on AA onset and severity can be identified using the C3H/HeJ mouse as a platform. This will be done by A) gene association approaches (test all candidate genes by first confirming significant transcript dysregulation (gene array data) and then moving mutated alleles (knockouts) onto C3H/HeJ to create informative congenic strains or onto B6.C3H congenic strains carrying the C3H QTLs, B) analysis of specific genes predicted to be mutated based on sequencing, expression levels, alternative splicing, etc. (traditional western and northern blots combined with other standard approaches); and C) utilization of C57BL/6J congenic strains that contain C3H/HeJ QTL intervals, one on each congenic strain, to prioritize QTLs, determine interactions, and reduce intervals (rule genes in or out). We will likewise use consomic strains available in our repository that are resistant to AA (C57BL/6J) but contain each of the 4 QTLs from the A/J susceptible strain to verify the same QTL intervals exist in A/J mice.